Data Management Core for SWOG SDMC

Project Summary/Abstract Data Management Core The Data Management Core is responsible for both the data management and computing needs of the SWOG SDMC. The Data Management Core provides management processes and procedures for delivering high quality and timely data on clinical trials. Specific goals include the following: (a) develop and optimize systems for the complete and timely collection, review, secure storage and retrieval of the highest quality data, complementing Medidata Rave and other standardized NCTN tools; (b) ensure timely and accurate adverse event monitoring and reporting; and (c) enhance existing and develop new software to best track patient specimens and translational medicine data and expand the use of the SWOG biorepository to the research community. The SWOG SDMC, primarily through the Data Management Core, facilitates these activities to ensure high quality and timely data using improved data forms, standardized data definitions, and reporting systems to maximize accuracy, and by providing education to investigators and site oncology research professionals on best practices for data management and electronic data capture principles. The SWOG Data Management Core has a significant history of developing high quality and innovative cross- trial software programs to enhance existing NCI tools to best manage data activities.